2021 Association of Environmental Engineering and Science Professors (AEESP) Research and Education Conference

The biannual Association of Environmental Engineering and Science Professors (AEESP) Research and Education Conference is an ideal platform for enhancing interactions between the environmental health science and environmental engineering communities. Three workshops and a panel discussion that we have proposed to foster increased interactions between environmental engineers and environmental health scientists are aligned with the theme of convergence that is embedded in the conference title “Environmental Engineering and Science at the Confluence.” The overarching objective of the AEESP Research and Education Conference activities that will be supported by NIEHS is to empower environmental engineering and science professors with new relationships and knowledge for solving environmental health science challenges. Specific objectives are to: (1) connect environmental engineering and science professors with knowledge and strategies for effective environmental health science research, (2) identify research opportunities and build collaborative relationships at the nexus of environmental engineering and environmental health sciences, and (3) broaden the participation of professors and future professors from universities and demographic groups that are underrepresented in environmental engineering and environmental health science. The workshops and platform panel discussion for which NIEHS support is sought fit within the overall three-day format of the AEESP Research and Education Conference. We anticipate 300-400 people participating in the workshops with about half of those participating in at least one of the workshops focused on environmental health science (i.e., at least 150 people). For the 2021 conference we are planning three workshops directly relevant to environmental health sciences: (1) Connecting Environmental Engineering Research to Environmenal Health Sciences, (2) Aerosol Science and Engineering and Public Health, and (3) the Microbiome in Environmental Engineering. A panel discussion on the convergence of research and action will highlight environmental health science through the themes of two speakers. The workshops and panel discussion will be coordinated by a sub-committee of the overall organizing committee, which is a diverse set of professors from four co-hosting universities. The travel grant selection process is modeled off of the impact/priority score rubric used by reviewers when assessing NIH proposals. We will implement a communication and outreach effort to seek appropriate representation of diverse participants at the conference. Overall conference planning has made efforts to provide affordable on-campus accommodations, family care options, accessibility to persons with disabilities, and an assessment plan.

Public health relevance
Three workshops and one featured panel discussion on environmental health sciences are being planned for the 2021 Association of Environmental Engineering and Science Professors Research and Education Conference in St. Louis. The overarching objective of the AEESP Research and Education Conference activities that will be supported by NIEHS is to empower environmental engineering and science professors with new relationships and knowledge for solving environmental health science challenges. NIEHS funds will be used to support the travel of three invited speakers and to provide travel grants to 24 workshop participants who might not otherwise be able to attend the conference.